Reducing Racial Disparities in Advance Care Planning within Neuro-Oncology

Project Summary: Reducing Racial Disparities in Advance Care Planning within Neuro-Oncology
The Agency for Healthcare Quality and Research has called for research that improves care planning in
racial/ethnic minorities as well as priority patient populations, which includes those who require end-of-life care.
Advance care planning (ACP) involves discussion and documentation of patients’ goals and is unfortunately
poorly executed for patients from racial and ethnic minority backgrounds. ACP is also especially important in
neuro-oncology, as patients have poor prognoses and often suffer from progressive cognitive decline
interfering with decision-making capacity. The proposed project’s central hypothesis is that identifying the racial
and cultural barriers to implementing timely ACP will enhance goal-concordant care in terminal neuro-
oncologic disease and reduce racial and ethnic disparities in end-of-life care. The rationale is that timely ACP
is a key component of goal-concordant care delivery for neuro-oncologic patients. This proposal will utilize
rigorous quantitative and qualitative research methods to answer the following innovative Aims: 1) to define
current ACP implementation patterns within a tertiary-care health system and analyze patient-level factors
contributing to the existing timing and content of ACP; 2) to identify patient- and provider-specific attitudes,
barriers and other factors involved in ACP implementation; and 3) to identify the most feasible and practically
implementable strategy available for addressing challenges and reducing disparities in ACP implementation in
the neuro-oncologic patient population. Dr. Adela Wu is a neurosurgery resident physician at Stanford
interested in improving end-of-life care for neuro-oncologic and neurosurgical patients. She seeks to receive
rigorous training in quantitative and qualitative research design, methodology, and planning necessary to
become an independent surgeon-scientist and a leader in neurosurgical oncology and palliative care with K
award and other career development funding. Under the close supervision of the mentorship team led by
nationally-renowned experts in palliative care and implementation science (Dr. Karl Lorenz), palliative care and
patient-centered outcomes (Dr. Rebecca Aslakson), biomedical ethics and communication (Dr. David Magnus)
and neuro-oncology management (Dr. Michael Lim), Dr. Wu will achieve the proposed research Aims. The
training plan includes regular mentorship meetings, formal didactic courses, and seminars to deepen
understanding of core research skills Dr. Wu will need to earn further career development funding and become
a successful, independent investigator. Furthermore, Stanford University is a highly regarded center for
biomedical research, with the oldest palliative care fellowship program nationwide, t
he Stanford Palliative Care
Center of Excellence, and a clinically busy neuro-oncology service and outpatient clinic at the Stanford Cancer
Center.

Public health relevance
Project Narrative Advance care planning is a critical component of goal-concordant care at the end-of-life, particularly for neuro- oncologic patients who suffer from both cancer and neurocognitive symptoms. Racial and ethnic minorities have disproportionately low rates of advance care planning implementation and documentation. This proposal will both define barriers and identify strategies to improve advance care planning in minority groups within the neuro- oncologic patient population.